Importation and transmission of malaria in Zanzibar: a case study for elimination

ABSTRACT
Over the past decade, malaria elimination has re-emerged atop the global health agenda, with most countries
setting goals to be malaria-free within two decades. However, major obstacles remain, including “getting to
zero” in regions that have achieved pre-elimination status but remain surrounded by areas of ongoing
transmission. As these regions near elimination, they are often “vulnerable” to re-introduction of malaria from
nearby areas and “receptive” as they have the right ecology to support transmission. The Zanzibar Archipelago
is one of these regions. Despite robust vector control and access to efficacious antimalarial treatment, its
proximity to mainland Tanzania has made elimination difficult. Specifically, eliminating malaria on the
archipelago requires a better understanding of why and where importation is occurring and understanding the
factors that promote local transmission. This proposal will overlay genomic studies onto ongoing Zanzibar
Malaria Elimination Program (ZAMEP) passive surveillance and reactive case detection (RCD) activities to
identify foci of imported cases on the islands (Aim 1A), model the relationship between human travel, parasite
genetics and importation (Aim 1B), determine the extent of secondary transmission from index cases (Aim 2A),
and show the limits of RCD in detecting index cases and capturing parasite outbreaks (Aim 2B). Samples will
be collected from every reported case on the archipelago and 10 sites on mainland Tanzania. Additionally,
enhanced RCD - screening households surrounding a reported index case, both 1 and 4 weeks later - will be
carried out in order to capture secondary asymptomatic cases, including those infected but with prepatent
infection, as well as those yet to be inoculated by infected mosquitoes at the time of first RCD. We will deploy
novel efficient high throughput sequencing methods that enable genotyping of thousands of samples on a
genome-wide basis. This strategy is much cheaper than whole genome sequencing but still provides the
resolution needed to use identity-by-descent analyses to infer relationships between highly related parasites.
These methods will allow us to define individual and community risk factors for importation, as well as
intervenable risk factors that impact the extent of local transmission arising from importation. Combined with
geospatial data on human mobility patterns, we will achieve a deeper understanding of the drivers of
importation and secondary transmission that will allow ZAMEP to tailor interventions at a local level. This study
leverages an existing productive collaboration between leading academic institutions (UNC, Brown, Imperial,
MUHAS) and ZAMEP to tackle questions cited amongst the highest research priorities for the WHO and other
bodies that guide malaria research. As all malaria endemic countries will face the last mile of malaria
elimination, whether now or in the future, we expect completion of the aims in this proposal to have a direct
impact on global malaria policies.

Public health relevance
PROJECT NARRATIVE Malaria elimination remains a global health priority, but as regions near elimination they are often “vulnerable” to re-introduction of malaria from areas nearby with high transmission and “receptive” as they have the right ecology to support transmission. Evidence is needed to design interventions to help pre-elimination settings reach the last mile of elimination. This proposal seeks to provide the evidence base to help develop the tools needed for control programs to face this challenge.